Models of EBV Cancer

CORE C – PROJECT SUMMARY
The Preclinical Models of Epstein-Barr Virus (EBV) Cancer Core provides major resources to the three Program
Project Investigators, including viral mutants and strains, EBV+ and EBV- nasopharyngeal carcinoma and
gastric carcinoma cell lines; human gastric cancer organoid cultures; patient derived xenografts and other in vivo
models of EBV-associated cancers; compound testing; and recombinant viruses. Core C has acquired a large
repository of EBV+ and EBV- epithelial (gastric and nasopharyngeal) and lymphoid cell lines that have been
fingerprinted and are routinely verified by microsatellite/short terminal repeat (STR) testing to exclude cross-
contamination. In collaboration with Dr. Calvin Kuo (Stanford University), gastric cancer organoid cultures that
are now continuously available through Core C at The Wistar Institute. Organoids are superior to standard cell
culture because they recapitulate many features of the organs that they are derived from, including organ
ultrastructure, and mimic the tumor microenvironment. These organoid cultures will provide important tools for
studying viral and cellular determinants of Epstein-Barr virus-associated cancers (Project 1) and for drug
screening (Projects 2 and 3). Importantly, these organoid cultures are genetically tractable and TP53 and
ARID1A knockout organoid cultures are already available in Core C.
In addition to cell culture models, Core C routinely performs studies using several murine models of EBV-
associated cancers. Patient-derived xenografts that are exclusively maintained in vivo are available for all three
Projects. Cell line-derived models of EBV associated gastric carcinoma and NPC have been adapted for
bioluminescent imaging studies. These murine models will be used for compound testing (Projects 1-3) in
collaboration with Core B. Finally, Core C will provide high-titer, recombinant EBV (Projects 1-3) using a
bacterial artificial chromosome system to interrogate the specific contributions of EBV genes to the development
of cancer.

Public health relevance
CORE C – PROJECT NARRATIVE This core supports the research Projects with viral, cell- and animal-based experimental tools and models, but also conducts experiments. The infrastructure comprises collections of EBV+ and EBV- nasopharyngeal and gastric carcinoma cell lines, gastric organoid cultures, and cell-derived and patient-derived xenograft models - each reflecting different aspects of EBV-associated cancers. A major effort of Core C will be to test compounds targeting these cancers in support of Projects 1-3. In addition, the core will provide recombinant EBV to characterize the viral contribution to disease pathogenesis and drug responses.